CORE--BIOSTATISTICS

DESCRIPTION (provided by applicant): The Biostatistics Core will (a) develop and maintain the central database of the SPORE and (b) provide biostatistical expertise for all aspects of the SPORE. The central SPORE database will be web based and will house the clinical, tissue and laboratory data of prostate cancer patients seen at the Northwestern Memorial Hospital and Evanston Northwestern Healthcare sites. Using current data collection systems as a basis, standardized procedures will be developed for collecting, checking, editing, entering, storing, managing and analyzing the SPORE data. The Biostatistics Core will interact extensively with the Clinical and Tissue Cores during the development and operation of the database. This core will have expertise in biostatistics, bioinformatics, database technology, systems programming and data entry. This mix of expertise will house all aspects of data management and analysis into this Core, thereby enhancing the efficiency with which SPORE informatics aspects may be viewed and dealt with on a daily basis. The Biostatistics Core is responsible for developing and maintaining the database, conducting statistical analyses and providing statistical input to study research design. This Core will be available at all times to provide input on design or statistical analysis to all SPORE investigators. This Core will also review procedures for data input and data quality control. Scientific input to the SPORE as a whole will be provided as direct input to the Executive Committee regarding the overall research of the SPORE. Scientific input by the Biostatistics Core will be provided to individual investigators of interpretation of statistical analyses and writing of manuscripts.